SOMATIC SENSORIMOTOR SYSTEM STUDIES IN RODENTS

The purpose of this project is to examine the mechanisms of recovery of function following damage to the neocortex in rats. In the past year, I have focussed on the behavioral effects of lesions in the caudal forelimb area of the somatic sensorimotor cortex. This project includes a comparison between the recovery patterns of rats receiving lesions as adult vs neonates as well as the effects of MK-801 (an noncompetitive antagonist at the N-methyl-D-aspartate receptor) when administered after behavioral recovery. The rat is the model species because the sensorimotor impairments following lesions have been studied most extensively in this species.